Revolutionizing Renal Histopathology: Integrating Multiplexed Immunofluorescence and ML/AI Image-Based Biomarkers for Precision Diagnosis and Patient Stratification

The accurate evaluation of kidney biopsy tissues is critical for diagnosing and managing individuals with
kidney diseases, which affect hundreds of millions of people globally. However, conventional histopathology
techniques have major limitations due to the reliance on manual interpretation and the lack of multi-marker
quantitative biomarker analysis, hindering precise diagnosis and treatment stratification. This proposal aims to
transform renal diagnostics by developing an advanced imaging and analysis platform based on Orion
multiplexed immunofluorescence (IF) imaging of up to 20 antibodies and same-section H&E staining. The
innovative platform will generate whole slide scans, allowing for quantitative assessment of protein levels and
their spatial co-location and relationships within tissues. By integrating advanced machine learning (ML) and
artificial intelligence (AI) methods, we will create a suite of multi-variate image-based biomarkers, that will
significantly enhance diagnostic precision and patient stratification. The platform is designed for broad
implementation across medical centers and research settings, promising immediate improvements in renal
diagnostics and patient management and catalyzing sustained biomarker innovation and implementation by
facilitating the collection of digital images and quantitative metrics on a large scale in data repositories. A key
element of this approach is the direct involvement of renal pathologists throughout the development process.
The reagents, methods, visualization, and analysis tools we create will be tailored to address current clinical
challenges, ensuring that renal pathologists become equipped with firsthand experience in advanced
quantitative renal imaging. This will foster their active participation in iteratively refining the assays and
biomarkers, maximizing clinical benefit and supporting new initiatives in precision medicine clinical trials. We
have strategically de-risked this project in several ways: (1) our team has extensive experience with the Orion
multiplexing platform, having co-developed it through a successful SBIR grant; (2) we have already developed
many of the primary analysis and visualization tools through our participation in the NCI Human Tumor Atlas
Network (HTAN), which we will now adapt for renal diagnostics; (3) we have achieved proof-of concept
imaging of kidney biopsies demonstrating the feasibility and positive reception of multiplexed kidney imaging
among renal pathologists and nephrologists (see LOS). Aim 1 will focus on developing 18-marker multiplexed
IF panels and a same section H&E protocol, enabling more comprehensive evaluation of common and rare
kidney diseases. We will create automated analysis workflows and standardized methods for protein
quantification and data normalization, as well as antibody cycling protocols to expand capabilities and the
depth of molecular phenotyping. Aim 2 will develop open-source analysis software for single and multi-marker
quantification, and new multiparameter metrics using ML/AI. This software will facilitate the evaluation of
complex biomarker data and drive evolution of kidney precision medicine.

Public health relevance
The current diagnostic practice in renal pathology relies predominantly on the visual inspection of single- marker histochemical stains and immunofluorescence across multiple tissue sections, which is inherently limited by the lack of quantitative and multi-marker spatial data. Our proposal aims to revolutionize renal pathology by developing and integrating advanced multiplexed immunofluorescence and multimodal technologies into a CLIA-ready platform, complete with new protocols, reagents, analysis algorithms, and machine learning/artificial intelligence-derived image-based biomarkers. This transformative platform will provide comprehensive, quantitative molecular data, enhance diagnostic accuracy and reproducibility, enable the collection of large-scale renal image repositories directly from clinical workflows to empower new biomarker identification, and catalyze the widespread adoption of precision medicine for chronic kidney disease, significantly improving patient outcomes.